Molecular mechanisms of cell fate determinant assembly

PROJECT SUMMARY
During embryonic development cells must be correctly allocated to distinct fates needed for organismal
growth and reproduction. Germ cells generate eggs and sperm and must be specified to avoid disorders of
the reproductive system, including gonadal and ovarian cancers, teratomas and other germ cell tumors, and
ultimately infertility. Germ cells often acquire their fate by inheriting cytoplasmic components that are
maternally synthesized, membrane-free, gel-like aggregates of proteins and RNAs collectively called germ
plasm. The highly conserved proteins, RNAs and organelles within germ plasm are assembled, or
nucleated, by other proteins that can be different in sequence across animals, but that share similar
evolutionary histories and biophysical properties. The molecular mechanisms by which these nucleators
ensure assembly and function of germ plasm remain unclear. Our long-term goal is to understand the
molecular mechanisms that drive the assembly and function of cytoplasmic fate determinants. In this
proposal, we will elucidate the mechanisms by which the Drosophila nucleator, encoded by the oskar gene,
assembles germ plasm. This proposal is significant because it has the potential to uncover generalizable
principles of germ plasm assembly, which may be broadly applicable to the formation and function of
membrane-less, gel-like cytoplasmic aggregates that regulate cell fates in many different contexts. Our
bioinformatic discovery of hundreds of new oskar sequences, combined with X-ray crystallography and
biochemical assays, suggested previously unexplored hypotheses for the molecular mechanism of oskar
function, which we will test as follows: In Aim 1, we will elucidate the role of the conserved LOTUS domain
in germ plasm assembly with in vitro biochemical assays and in vivo transgenic assays of the biological
function and biophysical properties of germ plasm, testing hypotheses regarding the importance of
dimerization, higher-order aggregate formation, phase separation, and Vasa binding to germ plasm
assembly. In Aim 2, we will determine for the first time the specific sequences and structural properties of
the Long Oskar Domain that enable the Long Oskar isoform to recruit and anchor mitochondria in the germ
plasm. In Aim 3, we will test the novel hypothesis that the conserved OSK domain interacts with specific
classes of lipids in the oocyte posterior, to help anchor Oskar to the posterior pole. Since defects in germ
cell development can lead to reproductive system pathologies affecting up to 12% of the US population,
elucidating the mechanisms that ensure assembly and function of germ line determinants is highly relevant
to human health. More generally, germ plasm is a type of ribonucleoprotein multimer (RNP), which are
membrane-free, gel-like organelles that regulate translation in both germ line and somatic cells.
Understanding germ plasm assembly may thus shed light on the general principles underlying assembly of
cytoplasmic RNPs required for the proper function of multiple critical cell types.

Public health relevance
PROJECT NARRATIVE In a developing embryo, all cells must acquire appropriate fates, including germ cells, which make eggs and sperm and are thus absolutely required for reproduction and species survival. This proposal will uncover the mechanisms that ensure that germ cells acquire their fates correctly by virtue of special cytoplasmic aggregates, which are similar to aggregates that regulate other types of cell fates in many somatic cells. Thus, the experiments proposed here will shed light both on how cells like germ cells are normally specified, and on why mutations in the genes encoding the molecular components of the cytoplasmic aggregates can lead to human disease.